Signal Transduction by PI3K/mTOR

Project summary:
The overall goal of our research is to uncover the molecular and cellular mechanisms by which mTOR
signaling is spatially regulated and to elucidate the contribution of subcellular mTORC1 signaling to
tumorigenesis and cancer therapy resistance. The signaling pathway regulated by phosphatidylinositol 3-
kinase (PI3K) and mechanistic target of rapamycin (mTOR) regulates a number of processes that are critical
to cell physiology, and therefore is often dysregulated in diseases, including cancer. In particular, persistent
activation of the PI3K/mTOR signaling circuitry is the most frequent dysregulated signaling mechanism in oral
squamous cell carcinoma (OSCC), a disease that results in ~300,000 deaths each year worldwide, with 5-year
survival estimates of approximately 60%, despite aggressive multimodality therapies. Spatial
compartmentalization of PI3K/mTOR is not only critical for enhancing the signaling specificity, but also
required for proper functioning of the pathway. However, the mechanisms underlying spatial regulation of
PI3K/mTOR signaling remain poorly understood and it is not clear which subcellular pools of the signaling
molecules contribute to tumorigenesis and therapy resistance. We have assembled a strong interdisciplinary
team with complementary expertise, including Dr. Jin Zhang, an expert in chemical biology and kinase
signaling, Dr. J. Silvio Gutkind, a renowned cancer biologist whose lab has focused on the study of oncogenic
signaling pathways driving OSCC initiation and progression. In our previous studies, we have created novel
tools for studying the spatial regulation of mTOR signaling, including a fluorescent biosensor for tracking
mTOR Complex 1 (mTORC1) activity in living cells and an approach for achieving subcellular inhibition of
kinase signaling. Using these tools, we discovered novel mechanisms underlying regulation of nuclear
mTORC1. In the context of OSCC, we have shown that mTOR inhibition exerts potent antitumor activity in a
large series of genetically-defined and chemically-induced OSCC models and favorable clinical responses in a
recently completed clinical phase II trial (NCT01195922). The current proposal will develop new molecular
tools to interrogate the spatiotemporal regulation of mTORC1 signaling in living cells, elucidate the regulatory
mechanisms of nuclear mTORC1 signaling, and determine the functional roles of subcellular mTORC1
signaling in tumorigenesis and Cetuximab resistance in OSCC. Unravelling the function and regulation of
subcellular mTORC1 signaling should offer a path toward selective targeting of pathway components and yield
therapies with reduced toxicity and resistance.

Public health relevance
Narrative: The overall goal of our research is to uncover the molecular and cellular mechanisms by which mTOR signaling is spatially regulated and to elucidate the contribution of subcellular mTORC1 signaling to tumorigenesis and cancer therapy resistance. Persistent activation of the PI3K/mTOR signaling circuitry is the most frequent dysregulated signaling mechanism in oral squamous cell carcinoma (OSCC), a disease that results in ~300,000 deaths each year worldwide, with 5-year survival estimates of approximately 60%, despite aggressive multimodality therapies. Unravelling the function and regulation of subcellular mTORC1 signaling should offer a path toward selective targeting of pathway components, yielding therapies with reduced toxicity and resistance.